Listening to Gulf War Vets: A Qualitative Inquiry into the Health Experience and Treatment of those with Chronic Multisymptom Illness

Anticipated Impacts on Veterans Healthcare: The first comprehensive qualitative study of the health
experiences of Gulf War era Veterans will yield significant insight into the features of effective care models and
treatments, as well as satisfaction with care. It will also create a rich, ongoing resource that can inform VA's
effort to improve customer service and care for Gulf War Veterans including a specific focus on those with
multisymptom illness and their caregivers. This research will identify better illness-specific health measures
and promising therapeutic approaches appropriate to VA settings. Finally, our goal is to activate Veterans to be
more engaged with the health system and VA research and policy processes, as well as to improve Gulf War
Veteran communication with VA care providers.
Project Background: While the proportion of Gulf War era Veterans seen in the VA is increasing rapidly, a
disproportionate number of these Veterans suffer from chronic multisymptom illnesses. Although great efforts
have been made to study the causes, we know little about the health experiences of Gulf War era Veterans
with or without multisymptom illnesses. Gulf War registry studies have used rigorous quantitative methods that
are well suited to broad and large-scale epidemiologic inquiry but are not well suited to characterize the
atypical symptoms, effects of co-occurring symptoms, particular challenges related to symptoms and symptom
combinations, and variations in symptom presentation among Gulf War Veterans with multisymptom illness.
Project Objectives: The overarching goal is to create a comprehensive repository of qualitative patient
interviews about experiences of Gulf War-related, chronic, multisymptom illness that can be used to motivate
system change; inform research, clinical practice, and VA policy; and provide an ongoing resource for
Veterans, caregivers, researchers, clinicians, and VA system leaders. The specific aims are: (1) Using
qualitative methods, amplify patient and caregiver voices in Gulf War-related research and clinical care to
improve understanding of experiences of illness and illuminate patient preferences which will contribute to the
design and conduct of patient-centered research and care models; (2) Using mixed methods, improve
understanding of the character of symptoms and functional problems specific to Gulf War era Veterans with
multisymptom illness, and provide this information as a resource to develop improved patient-reported
outcome measures; and (3) Using the results of these studies, develop products that identify promising
treatments, regimens, and care models that can be studied in randomized trials or implemented broadly
throughout the VA health system.
Project Methods: To achieve these objectives, we will use a proven methodology to structure the conduct of
video- and audio-taped interviews. The key features of this approach are (1) maximum variation sampling to
capture the widest possible range of views and experience and to ensure representation from marginalized,
seldom heard, historically underrepresented, and socially excluded groups; (2) in depth, individual interviews
with Veterans and caregivers rather than focus groups or questionnaires; (3) dissemination strategies that are
designed to accelerate system change and responsiveness to Veterans' problems; and (4) development of a
repository in which health experience research can be reapplied and updated rather than used for a particular
study and then lost. We will also employ mixed methods to ensure that broad and unbiased perspectives are
incorporated in our research and products, including (1) conducting surveys of Veteran participants to use in
triangulation and expansion mixed methods approaches, (2) linking findings with existing epidemiological
research, and (3) conducting a literature assessment according to IOM recommendations. These
comprehensive methods avoid bias in interpreting interview data and ensure consideration of factors
associated with key differences in patient experience (e.g., race/ethnicity, socio-economic status, gender
identity, sexual orientation, geographic region, previous treatment regimen, etc.).

Public health relevance
This large qualitative study of Gulf War Veterans will yield significant insight into the features of effective care models, treatments, and satisfaction with care. Interviews of Gulf War Veterans suffering chronic multisymptom illness by our team of experienced qualitative researchers will yield 1) significant insight into treatment regimens—from care both in- and outside the VA—that have the greatest patient benefit, 2) a more complete and nuanced understanding of symptoms that can be used for more directed treatment, and 3) publicly available resources that can be used by veterans, caregivers, clinicians, and researchers. It will also create a rich, ongoing resource that can inform VA’s effort to develop better care models for Gulf War veterans, identify better illness-specific health measures and promising therapeutic approaches, and activate veterans to be more engaged with the health system.